Long-term impact of universal treatment and dolutegravir on population HIV virologic and incidence outcomes in Africa: The LONGVIEW Study

PROJECT SUMMARY
Despite rollout of Universal Test-and-Treat (UTT) in Africa, HIV incidence has declined only modestly with no
country on track to meet UNAIDS 2030 targets for epidemic control. Control efforts are challenged by both
“hard-to-engage” HIV-positive persons who remain viremic as well as HIV drug resistance (HIVDR) which has
prompted the recent rollout of dolutegravir (DTG). While UTT and DTG are likely to result in lower levels of
viremia and HIVDR, there is uncertainty about the magnitude and durability of their population-level impact.
Provision of UTT and DTG has been disrupted by the recent COVID-19 pandemic in Uganda and the social
distancing and mobility restrictions implemented to contain transmission. Here, we propose the Longitudinal
Viral Load and Epidemiological Watch (LONGVIEW) Study, a prospective assessment of the impact of COVID-
19 disruption on UTT and DTG programmatic outcomes, including durable population viral load suppression,
HIVDR, and HIV incidence in southcentral Uganda. This study will be nested within the Rakai Community
Cohort Study (RCCS), a population-based study of ~20,000 persons, aged 15-49, in 40 communities with HIV
prevalence ranging from ~9-40% and transmitted HIVDR ~20%. We propose to measure viral loads and
perform deep sequence viral phylogenetics on all HIV-seropositive participants over seven RCCS surveys
(n~3800 HIV+ per survey) from 2013-2025, spanning introduction of UTT in 2017, DTG in 2019 and COVID-19
in 2020. In Aim 1, ~18,500 HIV viral loads will be determined for all HIV-positive RCCS participants at all study
visits. Group-based multi-trajectory analysis will be used to assess viral load suppression over time and deep
sequence phylogenetic data from all viremic participants (>1,000 HIV copies/mL) will assess HIVDR. In Aim 2,
we will use quantitative and qualitative methods to assess the impact of COVID-19 on HIV treatment seeking,
utilization, and care provision. Specifically, we will identify HIV-positive individuals who report interruptions in
HIV care and conduct in-depth interviews to assess the extent and nature of ART care disruption. We will also
conduct focus group discussions and in-depth interviews with HIV service providers to assess the impact of
COVID-19 on provision of HIV care and treatment. In Aim 3, we will evaluate trends in HIV incidence and risk
of HIV transmission across the infection and care continuum before and after COVID-19 emergence. We will
use longitudinal RCCS data to estimate HIV incidence as well as HIV transmission risk within household-based
partnerships. Deep sequence viral phylogenetic data will be used to reconstruct directed transmission
networks and estimate the attributable fraction of transmissions across the care continuum. This study will
provide empirical data on the impact of the COVID-19 pandemic on population HIV virologic and incidence
outcomes in a “real-world” programmatic setting. The overarching goal of this study is to measure the
impact of COVID-19 on UTT services, longer-term HIV viremia, drug resistance, and HIV incidence to inform
HIV control and elimination strategies in Africa.

Public health relevance
PROJECT NARRATIVE The extent to which African HIV universal treatment programs can reach all HIV-positive persons and suppress them over their entire lives as well as reverse rising trends in HIV drug resistance remains unknown. Moreover, the introduction of the COVID-19 pandemic has disrupted HIV treatment and prevention services. This study aims to measure the impact of COVID-19 on key HIV programmatic outcomes, including HIV viremia, drug resistance, and new cases of HIV in a Ugandan population with a high HIV burden.